Deep Learning of Mass Spectrometry Imaging

PROJECT SUMMARY
Mass spectrometry imaging (MSI) is a rapidly developing technology which gives pathologists many new types
of targets (e.g., metabolites and lipids) to assess for translational cancer research. However, the resulting data
are even more complex than traditional images because they are highly-dimensional, and large (~100GB per
tissue section). Each “pixel” in the resulting data structure contains a 2-dimensional mass spectrum made of
both measured ion mass and ion mobility (m/z, 1/K0), and each spectrum typically contains hundreds to
thousands of individual ions (metabolites and lipids). Deep-learning methods (machine learning) have been
successfully applied to histopathology data by several laboratories including Dr. David Fenyo, Co-Investigator of
the current proposal, with such models being able to discriminate between different cancer subtypes and grades
for example. However, most machine learning models of image-data are designed around 3-data channels (Red,
Green, Blue) for analysis of digital images. Therefore, the n-dimensional data structure of mass spectrometry
imaging datasets is not easily amenable to these proven machine learning workflows. We will make MSI data
accessible to these approaches by expanding to n-dimension “color-channels”, with each unique metabolite or
lipid image serving as an individual data input. For the deep learning component, we will retain the same overall
architecture and workflow of the Panoptes tool, published by Fenyo et. al., (Cell Reports, Medicine, 2021) but
we will apply an n-dimensional approach and test the data structure on existing data which has parallel H&E
stain information annotated by pathologists. These challenges are addressed in Aim1 of the current proposal,
while Aim 2 addresses a closely related challenge of detecting image correlations both within and between these
data structures and other imaging modalities. Image correlations within such data are more trivial, but these
analyses are not well supported by existing academic or vendor software due to the amount of computation
needed for hundreds of data dimensions. We further propose and test an approach for converting these multi-
dimensional data into centroided single ion images, followed by linearization of the image to enable a simple
Pearson correlation metric, thereby making a complete correlation matrix accessible by a scaling factor of n2 to
the number of detected ions. Secondly, to deal with spatial correlations between MSI datasets and images from
other modalities, or adjacent tissue sections which may be different in size and shape, we propose to implement
a spatially aware elastic transform of the centroided image data prior to correlation analysis and machine
learning.

Public health relevance
PROJECT NARRATIVE Mass spectrometry imaging (MSI) gives pathologists many new types of targets (metabolites and lipids) to research for cancer diagnosis, but the data are even more complex than traditional images. The current proposal will make MSI data accessible to machine learning approaches, which will enable researchers and pathologists to easily correlate known markers with novel metabolite and lipid ion images by addressing several of the current hurdles.